Mechanism and Regulation of U1 snRNP Telescripting

PROJECT SUMMARY
This proposal’s overall goal is to understand the molecular mechanism of telescripting, a new and major gene
expression process that is crucial for full-length transcription of most protein-coding genes and regulates
messenger RNAs (mRNAs) isoforms and mRNA length in humans and other complex organisms. mRNAs are
processed from nascent RNA polymerase II (PolII) transcripts, which generally includes the removal of introns
(splicing) and transcription-terminating 3’-end cleavage and polyadenylation (CPA). Splicing and CPA are
specified by splice sites and CPA signals (PASs), respectively. However, numerous PASs indistinguishable
from the ultimate, gene ends’ PASs are scattered throughout pre-mRNAs, especially in introns and 3’
untranslated regions (3’UTRs), and can trigger premature CPA (PCPA). PCPA is suppressed by U1 snRNP
(U1), human cells’ most abundant small non-coding nuclear RNA-protein particle. For brevity, and to
distinguish it from U1’s role in splicing, we call U1 suppression of PCPA, telescripting (as it is necessary for
long-distance transcription). Like U1 function in splicing, telescripting also depends on U1 snRNA base-pairing
to nascent transcripts, which can be abrogated with U1 antisense oligonucleotides (U1 AMO), causing PCPA.
Recent studies revealed that even slight changes in the balance between U1 and PASs has great impact on
gene expression and can profoundly alter the mRNAs and proteins cells produce. Such changes occur
naturally, for example rapid transcription up-regulation during cell stimulation, and create transient U1 deficit
relative to transcription output, causing PCPA that produces shorter mRNA isoforms needed to respond to
acute environmental changes. Importantly, U1 AMO recapitulates the same mRNA isoform shifts and U1 over-
expression can prevent their production in stimulated cells. U1 AMO also elicits widespread 3'UTR shortening,
which occurs in and contributes to cell proliferation and cancer.
U1 telescripting’s overarching role in transcriptome regulation impacts transcription, splicing, CPA and thereby
all downstream events in the life of mRNAs. It has numerous potential applications in biology and medicine.
Realizing them requires detailed understanding of the molecular mechanism by which U1 suppresses PASs
and the factors that regulate it, which remain unknown. We have made significant progress towards that,
including mapping the transcriptome binding locations of U1 and cleavage and polyadenylation factors
(CPAFs), and interpreted them in relation to PCPA locations. We have also captured U1 and CPAFs
complexes in cells, determined their compositions and stoichiometries, and determined how cells produce the
great U1 abundance required for telescripting. These advances lay the foundation for future studies. I
anticipate the mechanistic studies and new information will identify potential points of intervention, including
druggable targets, and will advance the prospects of harnessing them for novel therapies.

Public health relevance
PROJECT NARRATIVE The proposal’s overall goal is to investigate the mechanism of a fundamental process necessary for biosynthesis of messenger RNAs, key intermediates in the flow of information from genes to proteins. This recently discovered process, termed telescripting, is crucial for protecting nascent gene transcripts and enhances cells’ ability to produce a great diversity of proteins they need for their functions and to changes in their environment. Telescripting changes can profoundly affect expression of genes associated with many diseases and knowledge of its mechanism will advance prospects of new therapies.